Applied Genomics in Infectious Diseases

Project Summary/Abstract
The intersection of genomics and infectious diseases has defined one of the most important leading edges in
contemporary science and one of the most critical areas of advancement in medicine, and as a result, has
provided a rich intellectual foundation for the training of postdoctoral scholars in infectious diseases. The
objectives of the grant are to train M.D. and Ph.D. post-doctoral fellows in the application of genomics to
infectious diseases, and to prepare them for successful, productive, independent careers that have a
significant impact on the health-related research needs of the nation. We propose to prepare all trainees
irrespective of whether they intend to conduct their research at the bench or from the bedside, in fundamentals
of both genomics and applied clinical investigation, with the goal of enhancing the translation of scientific
discoveries into clinical practice. We request support for five postdoctoral fellows each year - Ph.D. candidates
who have completed their thesis work and M.D. candidates who have completed their clinical training will be
evaluated by the Program's Steering Committee and offered admission on the basis of exceptional academic
record, faculty interviews, and interest in, and aptitude for research. Every effort will be made to attract minority
candidates. The training program will be interdisciplinary, involving faculty from Biology, Biochemistry,
Bioengineering, Chemical Engineering, Chemistry, Emergency Medicine, Genetics, Medicine, Microbiology &
Immunology, Pathology, and Pediatrics. All fellows will train for at least two years. Each trainee will be
encouraged to take courses in clinical research and in basic sciences related to genomics. Additionally, each
trainee will complete a two-year interdisciplinary core curriculum in applied genomics of infectious diseases.
Beginning in the first year, each fellow will embark on an in-depth research project supervised by one or more
of the Program's faculty; in many cases, joint-mentoring will involve faculty from different disciplines. In this
way, many research projects will be cross-disciplinary. Seminars by trainees and an annual research retreat
will promote interactions between program participants. While support from the Training grant will be for two
years, all fellows will be encouraged to begin to seek independent support after the first year. We will also
consider funding for a third year if needed for a trainee’s trajectory. The program intends to meet a recognized
need for clinician-scientists in Infectious Diseases who are trained in functional and applied genomics – a
recognized strength at Stanford University School of Medicine. This training grant has been, and continues to
be the primary source of postdoctoral research training support for clinician-scholars. Trainees are expected to
transition to independent positions in academia or industry, or positions in public health leadership and apply
their education in genomics to address pressing issues in infectious diseases.

Public health relevance
Project Narrative The objectives of the grant are to train M.D. and Ph.D. post-doctoral fellows in the application of genomics to infectious diseases, and to prepare them for successful, productive, independent careers that have a significant impact on the health-related research needs of the nation. The training program will exploit the world-class resources and leadership at the host institution in the field of genomics. Graduating trainees from this program will be unusually well-prepared to enhance the public health through the application of this powerful field of science.